Neural Markers of Treatment Mechanisms and Prediction of Treatment Outcomes in Social Anxiety

PROJECT SUMMARY/ABSTRACT
Social anxiety disorder (SAD) is one of the most common mental disorders. For unknown reasons, many
patients do not respond to existing treatments. Treatment guidelines and systematic reviews often recommend
CBT as the first line treatment, followed by an SSRI adjunctively for patients who show no or only partial
response to CBT. A major advance toward personalized medicine would be to identify reliable treatment
predictors, and then to clarify the neuromechanism of treatment change. One promising approach toward
improving patient outcomes is to examine the key neurocircuitry of SAD that may also serve as neuromarkers
predicting treatment response. We have gathered convincing pilot data identifying neuromarkers that predict
response to CBT in adults with SAD. The next translational step, and our primary aim, is to apply state of the
art computational psychiatry approaches to strengthen the evidence base for these neuromarkers, in line with
moving psychiatry toward precision medicine. This aim will be efficiently achieved by collecting state-of-the-art,
multimodal neuroimaging data to better elucidate the key neurocircuitry of SAD (compared to controls) in a well
powered sample, while also identifying differential treatment-related changes in neural circuitry (target
engagement). The ultimate goal is to effectively treat all patients, not only a few and without knowing why, and
to illuminate the brain circuitry associated with effective treatments to inform psychopathology, nosology, and
therapy of common mental disorders. For these reasons, we propose recruiting a large number of patients with
SAD (n = 190) and healthy controls (n = 100) to examine differences in relevant neurocircuitries that will also
be used as neuromarkers of treatment response. Patients with SAD will first receive CBT group therapy. Those
who show no or only partial response will then receive individual and tailored CBT plus SSRI. In addition to
MRI, we will examine EEG and behavioral measures to determine if there are more cost effective correlates of
neuropredictors that could be easily implemented in clinical practice. We have assembled a team of skilled
researchers with complementary expertise at the Massachusetts Institute of Technology (MIT; John D. E.
Gabrieli, Ph.D.), Boston University (BU; Stefan G. Hofmann, Ph.D.), and McLean Hospital (Daniel Dillon,
Ph.D.), as well as outstanding consultants in neuroimaging analysis (Northeastern University: Susan Whitfield-
Gabrieli, Ph.D.) and machine learning applications in psychiatry (McLean Hospital: Christian Webb, Ph.D.).

Public health relevance
PROJECT NARRATIVE Social anxiety is a common and chronic problem but, for unknown reasons, many patients do not respond to existing treatments. Despite advances in neuroscience and computational psychiatry, there remains no reliable predictor of treatment response that can be used to select an optimal treatment for a given patient. The goals of the proposed research are to examine whether neuroimaging can offer an evidence-based precision or personalized medicine approach to predict treatment in patients with social anxiety, and to apply advanced computational and multimodal imaging approaches to improve our understanding of the neurobiology of social anxiety disorder, and brain changes (plasticity) associated with treatment response.